An eHealth intervention to increase depression treatment initiation and adherence among Veterans referred for mental health services

Background: Depression is the most prevalent mental health disorder in VHA and is strongly
associated with disability and suicide mortality, especially when untreated. Understanding the
profiles of patients that disengage from care will help develop support systems to improve care
utilization and outcomes. According to Levesque’s framework, relevant patient characteristics that
lead to care access map onto a process that incorporates identifying health care needs and desire
for care, healthcare seeking, reaching, and utilization, all leading to health care outcomes. Using this
framework, the proposed CDA takes a two-prong approach in response to underutilization of care
among those with depression by: developing risk predictive models through analytics methodology
and leveraging the role of mood and symptom self-monitoring as key components in depression
management. Significance/Impact: The knowledge developed through this CDA has long term
implications for OEF/OIF Veterans who are at highest risk for depression and suicide. Depression
has a significant impact on Veterans, providers, and the VA. It is a disorder that is linked to
substantial medical and economic burden in the VA. Depression is a risk factor for the development
and maintenance of medical and psychiatric conditions (i.e., PTSD, TBI). Despite persistent efforts
to increase care for depression, treatment guidelines are exclusively focused on those engaging in
care. Pre-treatment interventions have the potential to increase mental health care utilization and
reduce depression related burden on patients and the VA. Such interventions can minimize provider
burden by reducing no shows and by increasing adherence. Innovation: Research shows that the
VA has the potential to foster the development of tools to enhance mental health care for Veterans.
To fill gaps in the use of analytics and technology in enhancing care for mental health concerns, the
proposed work is innovative in two ways: 1) we propose the use of big data and analytics tools to
identify patient profiles associated with mental health treatment engagement and increased risk for
drop out of care; 2) develop a technology driven intervention to increase self-efficacy and active
engagement in mental health care. Specific Aims: RA1: Identify risk profiles (scores) associated
with depression treatment use. Test prediction models using VHA electronic health records (EHR).
Risk scores computed in Aim 1 will be used in selection of patients at risk and eligible for the
proposed intervention.TA1: Gain proficiency in methods and analysis of EHR/big data. RA2: Design
an eHealth intervention using technology driven self-monitoring. TA2: Develop skills and knowledge
about intervention development. RA3: Formatively evaluate and pilot the eHealth intervention. TA3:
Gain proficiency in formative evaluation. Methodology: RA1 will use a retrospective cohort design.
Leveraging the strengths of EHR data and analytics tools, we will investigate risk models to identify
patient profiles associated with treatment initiation and adherence. Predictors will be extracted from
structured data. RA2 is a development aim. We propose to design and formatively develop an
eHealth intervention primarily using technology driven self-monitoring of depressed mood and
symptoms. RA3 is a formative evaluation and pilot aim focused on the use of the intervention among
OEF/OIF Veterans with probable depression (N= 15). Next Steps/Implementation: This CDA will
help to establish a foundation for future efficacy/effectiveness research on interventions to increase
treatment utilization among Veterans with depression. Results will be used to inform the submission
of a RCT IIR in year 3 of the CDA to evaluate the efficacy/effectiveness of this intervention. Tools
developed in this CDA will contribute to VA innovation goals.

Public health relevance
Depression is the most prevalent mental health condition among VHA patients and is strongly associated with poor functioning, negative health outcomes, and suicide. Despite effective and available treatments, engagement in care is poor. This study will analyze VHA electronic medical record data, to identify patient characteristics associated with poor treatment engagement. The study will then develop and formatively evaluate an eHealth intervention to improve and sustain engagement in mental health care through self-monitoring. This is an important step in engaging Veterans who, in part, based on their military training, may have difficulty identifying or accepting depressed affect and the benefits of treatment. The information obtained will inform clinical strategies and operations policy to improve quality, coordination, and efficiency of mental health services.